Meharry Research Facilities for Advanced Genomics (MeRFAG)

Project Summary
The proposed application aims to establish the “Meharry Research Facilities for Advanced
Genomics” (MeRFAG) at Meharry Medical College (MMC), an Institution of Emerging Excellence
(IEE) in the southern United States dedicated to educating healthcare professionals and
biomedical scientists with a focus on addressing health disparities. The proposed MeRFAG will
serve as a state-of-the-art research environment, attracting high-calibre committed genomics
scientists, fostering cross-fertilization of ideas, innovation and interinstitutional collaboration to
advance biomedical and translational research. MeRFAG will enhance MMC’s partnerships with
academic and industry collaborators, including the genetics-focused Visiting Scientists Program
with the Icahn School of Medicine at Mt Sinai, NY, genomic studies through the Diaspora Human
Genomics Institute (DHGI) incorporated by MMC, and the NHGRI-funded Center for Genome
Research at MMC. It will also support the Together for CHANGE (T4C) initiative, a ten-year project
to recruit 500,000 volunteers of African ancestry for a biobank to advance health studies. In
keeping with demands for the diverse genomics workforce, T4C will also develop STEM
mentoring pathways for capacity building, such as the DNA Learning Center in collaboration with
Cold Spring Harbor Laboratory and a Genetic Counseling Training Program. The T4C initiative
governed by DHGI is funded by the Regeneron-led biopharmaceutical consortium. In keeping with
demands for the diverse genomics workforce, T4C is developing STEM mentoring pathways for
genomics capacity building. Additionally, MeRFAG will complement MMC’s partnership with the
Chan Zuckerberg Initiative to Accelerate Precision Health, which is recruiting faculty in MMC’s
new department of Integrative Genomics to focus on clinical and basic genomics to address
disease etiology and treatment. MeRFAG will also strengthen national programs like the Meharry-
led Southeast Hub of NIH AIM-AHEAD program and the DoE-funded TSU-MMC-Fisk alliance,
aimed at building competitiveness in diverse workforce. Approximately 17,898 sq ft of unused
space will be renovated to house a cluster of eight research core facilities in the proposed MeRFAG
with distinct capacities of a Biorepository, Digital Pathology, Transcriptomics, Pharmaco &
Toxicogenomics, Microbial genomics, Mitochondrial genomics, Immunogenomics and Immune
cell therapy, and Single Cell Sequencing and NGS. These facilities will enable a broad scope of
cutting-edge genomics research addressing health disparities, reduce startup costs for new
faculty, and attract high-caliber researchers. By integrating innovative research capabilities,
MeRFAG will position MMC and middle-TN as a leader in genomics-driven healthcare research.